Transdisciplinary Conference for Future Leaders in Precision Public Health

PROJECT SUMMARY
Increasingly, genomics is being integrated into population-level cancer prevention and control approaches
through precision public health. Given that the field is still emerging, there are limited opportunities for
investigators to come together to form collaborations and to build capacity for research. Thus, our goal for this
R13 renewal application is to convene an annual transdisciplinary conference for investigators who work in this
field to support capacity building in transdisciplinary precision public health research, with a focus in cancer over
the next three years. Our target audience emphasizes engaging early career investigators in cancer precision
public health who are in a pivotal moment in their career for establishing professional networks and identifying
research priorities. Our specific aims for the conference are to (1) increase content knowledge and methods
expertise in cancer precision public health through seminars and question and answer sessions; (2) advance
research priorities for cancer precision public health; and (3) maintain an ongoing professional network of
precision public health researchers in cancer to facilitate future collaborations in precision public health research,
training, and practice. Through this international conference, investigators from around the world will convene
annually to gain new content expertise, to advance key research priorities for the field, and to establish an
ongoing collaborative network to advance precision public health research. This builds on the work of our
inaugural conference which established key research priorities, an ongoing working group to advance these
priorities, and a network of precision public health researchers and practitioners who meet quarterly for webinars
on advanced topics in precision public health in cancer. Moreover, the conference themes will reflect the research
priorities identified in the 2021 conference: implementation science (2023 at University of North Carolina Chapel
Hill), health equity (2024 Medical University of South Carolina) and capacity building (2025 University of
Technology Sydney). Our long-term goal is to maintain a platform for early career investigators interested in
precision public health to come together to support the development of the precision public health research
agenda.

Public health relevance
PROJECT NARRATIVE The Transdisciplinary Conference for Future Leaders in Precision Public Health aims to develop and sustain a conference that provides a space for early career investigators who work in the field of cancer precision public health to come together to support capacity building for the field. This conference will annually convene 150 precision public health investigators and practitioners, from around the world to increase knowledge, to advance key research priorities for the field, and to establish an ongoing collaborative network to advance precision public health research in cancer. The long-term goal of this conference is to build capacity for and the impact of precision public health.